Planning and Evaluation Core

(This Core is identical for all three Partnering Institutions)
The Partnership between the Morehouse School of Medicine (MSM), Tuskegee University (TU), and the
University of Alabama at Birmingham O’Neal Comprehensive Cancer Center (UAB OCCC) presents a distinct
opportunity to build on our accomplishments in education of future cancer research scientists and to advance
cancer research at all three institutions with a focus on cancer outcomes in the context of a bidirectional
engagement with urban and rural communities in Alabama and Georgia. For this U54 Partnership, evaluation is
conducted by a team of evaluators representing each partnering institution, who meet monthly to discuss
progress, issues, and solutions: Dr. Isabel Scarinci and Ms. Kathryn Maxwell (UAB OCCC), Dr. Desiree Rivers
(MSM), and Mr. Lecarde Webb (TU). Although they work together, each is primarily responsible for specific
Cores and Shared Resources. This team makes recommendations to be implemented administratively by the
Principal Investigators with the advice, guidance, and direction of each institution’s Executive Committee, the
Partnership Leadership Committee (PLC), the Internal Advisory Committee (IAC), and the Program Steering
Committee (PSC). Each Core, Research Project, and Shared Resource of this Partnership have its own
evaluation plan/worksheet outlining the evaluation questions for each specific aim, tasks, data collection tools,
the person responsible for each task, and timeline. Process evaluation results are discussed monthly at the PLC
meetings, and comprehensive yearly written reports are shared with the IAC and PSC for feedback and
guidance. It should be noted that, although each component have its own evaluation plan, an integrated
evaluation process will be conducted to synergize all components to achieve the long-term goal of eliminating
cancer burden.

Public health relevance
The Planning and Evaluation Core will evaluate the impact of research projects, cores, and shared resources of the Morehouse School of Medicine, Tuskegee University, and University of Alabama at Birmingham O’Neal Comprehensive Cancer Center Partnership in achieving its programmatic goal of reducing cancer burden.